Prions in the bacterial domain of life

ABSTRACT
Prions are infectious, self-propagating protein aggregates that were first described in the context of the
transmissible spongiform encephalopathies (TSEs), a group of fatal neurodegenerative diseases that afflict
humans and other mammals. The culprit in the case of the TSEs is an endogenous protein called PrP that has
an inherent ability to undergo a dramatic conformational conversion, leading to the formation of distinctive
cross-b aggregates (termed amyloid) that are both self-templating and infectious. Prions have also been
uncovered in budding yeast and other fungi, where they act as protein-based genetic elements that confer new
heritable phenotypes on those cells that harbor them. Like PrP, fungal prion proteins can access alternative
conformational states, a soluble form and a self-perpetuating, amyloid form (the prion form) that is infectious.
Unlike PrP-based prions, however, fungal prions do not typically cause cell death; they can, in fact, enhance
cell survival under specific stress conditions. The foundation for the proposed studies is our discovery that
prion proteins also exist in bacteria. Our research goals are to investigate the scope of prion-like phenomena in
bacteria and to probe the physiologic significance of prions in bacteria. An overarching hypothesis informing
our work is that protein-based heredity can serve as an epigenetic source of phenotypic diversity in the
bacterial domain of life. As well as using E. coli cells as a model in which to study prion proteins from diverse
bacteria, we are extending our studies to encompass species that naturally contain prion proteins, including
constituents of the human microbiota. A major methodological focus of our long-term research program has
been the development of broadly applicable genetic assays, and our work here includes the development and
implementation of bacteria-based genetic assays that can detect prion conversion events. These genetic tools
will enable screening for prion protein encoded in bacterial (and other) genomes, facilitating the discovery of
new prion proteins and potentially also new classes of prion proteins. At the same time, our tools provide facile
methods for addressing mechanistic questions about prion formation and prion propagation. Our approach to
understanding prion biology is multi-faceted, encompassing ongoing collaboration with structural biologists and
biophysicists. Because prion proteins in all domains of life share fundamental properties, what we learn in
bacteria could provide mechanistic insight relevant to prion proteins in other settings; furthermore, our bacteria-
based tools can be used to investigate the behavior of bacterial and non-bacterial prion proteins alike.
Bacterial prions could have far-reaching human health implications; for example, as a source of non-genetic
phenotypic heterogeneity, prions might enhance bacterial fitness in a pathogenic context. Moreover, the
presence of prions in the human microbiota could potentially impact human health via cross-Kingdom
templating interactions involving disease-associated human proteins.

Public health relevance
PROJECT NARRATIVE First uncovered in the context of the fatal transmissible spongiform encephalopathies, prions are infectious, self-propagating protein aggregates that also exist in yeast and other fungi, where they act as heritable, protein-based genetic elements that can enhance survival under specific stressful conditions. The recent discovery of bacterial prions provides the foundation for the proposed studies, which will explore the scope and significance of prion-like phenomena in bacteria. The human health implications of bacterial prions could be far-reaching, from potential roles in antibiotic tolerance and immune evasion in the context of infection to potential effects on the human proteome via cross-Kingdom templating interactions within the human microbiota.